Dual function for an effector immunity protein in Pseudomonas aeruginosa biofilm biogenesis

ABSTRACT
Cystic fibrosis (CF) is characterized by the formation of thick mucus in the respiratory tract contributing to
chronic infections of numerous pathogens, including commonly Pseudomonas aeruginosa (Pa). Pa forms
robust biofilms, aggregates of bacteria encased in a protective extracellular matrix, in the airways of people
with CF (pwCF) and is a major cause of morbidity and mortality for pwCF. Pa harbors a wide repertoire of
competitive mechanisms that mediate host-microbe and microbe-microbe interactions. One such defensive
mechanism is the type VI secretion system (T6SS) which is known to be expressed during respiratory infection
in pwCF. The T6SS apparatus transports diverse effectors, one of which is TseT. The tseT operon consists of a
PAAR/tip protein, chaperone proteins, the effector TseT, and its cognate immunity protein TsiT. Preliminary
results found that deletion of the tseT operon decreases Pa biofilm growth in association with human CF
bronchial epithelial cells and expression of TsiT alone is sufficient to restore biofilm production in the tseT
operon mutant. Thus, the T6SS immunity protein TsiT is important for Pa biofilm growth, but the mechanism is
unknown. TsiT has sequential and structural homology to a general LysR-type transcriptional regulator (LTTR).
LTTRs are known to regulate diverse genes including those involved in virulence, metabolism, and quorum
sensing. Homology to LTTRs suggests a secondary, unconventional function for TsiT, in addition to its role as a
traditional T6SS immunity protein. This application aims to test the hypothesis that TsiT has a secondary
function as a transcription factor that regulates biofilm. As TsiT is conserved across several Gram-negative
bacterial pathogens, this work will provide far reaching insights into biofilm regulation and thus clinical
treatment. The applicant plans to pursue a career in academia in the area of host-pathogen interactions.
Support for this application will enable her to hone skills in bioinformatics and biochemistry, acquire experience
mentoring/teaching, experience with manuscript and grant preparation, and experience presenting to diverse
audiences. This application will not only provide a broad range of laboratory techniques, but also provide
transferrable skills for her long-term goal of becoming an academic researcher.

Public health relevance
PROJECT NARRATIVE Pseudomonas aeruginosa (Pa) forms robust biofilms, aggregates of bacteria encased in a protective extracellular matrix, in the airways of people with cystic fibrosis (pwCF) and is a major cause of morbidity and mortality for pwCF. This application proposes that TsiT, a type VI secretion system (T6SS) immunity protein which is highly conserved across Gram-negative bacterial pathogens, has a secondary function as a transcription factor that regulates biofilm. The project will serve as a foundation for the candidate to develop skills as an academic researcher and provide far reaching insights into biofilm regulation and thus clinical treatment.